Intercalated disc-nuclear lamina coupling as a molecular substrate for arrhythmogenic cardiomyopathy

Plakophilin-2 (PKP2) is classically defined as a protein of the desmosome, an intercellular adhesion structure
residing in the cardiac intercalated disc (ID). Mutations in PKP2 associate with most cases of gene-positive
arrhythmogenic right ventricular cardiomyopathy (ARVC), a disease characterized by high propensity to life-
threatening arrhythmias and myocardial structural damage, often of right ventricular predominance. Much
attention has been given to the loss of cell-cell attachment at the ID as a disease mechanism. Yet, it is becoming
evident that PKP2 mutations also lead to an array of poorly understood cardiomyocyte (CM)-intrinsic
disturbances. Desmin intermediate filaments are anchored to the desmosome in a PKP2-dependent manner,
supporting CM structural integrity and facilitating communication from the cell surface to the nucleus. Our prior
work in mouse models and human patient samples found PKP2 mutation disrupts CM nuclear envelope (NE)
integrity and leads to DNA damage. Based on published reports and our preliminary data, we hypothesize that
PKP2 deficiency, or disease relevant PKP2 mutations, disrupt the structural, functional and molecular integrity
of the cardiomyocyte nuclear envelope, leading to genomic reorganization, the DNA damage response, and
altered transcription. The following aims will investigate how PKP2 deficiency disrupts the nucleus to accelerate
ARVC disease progression.
Aim 1: Define the impact of PKP2 deficiency on the cardiomyocyte nuclear lamina protein interactome.
We hypothesize that PKP2 deficiency alters the proteome of the cardiomyocyte NE, and that this disruption is
an early trigger for the disease phenotype. We will interrogate changes in the molecular ecosystem of the
cardiomyocyte NE after loss of PKP2 expression using proteomics and single molecule imaging.
Aim 2: Define the impact of PKP2 deficiency on cardiomyocyte genomic organization.
We hypothesize that loss of NE integrity in PKP2 deficient CMs disrupts genomic organization at Lamin
Associated Domains and causes transcriptional remodeling. We will determine how structural damage is
transmitted from the cell membrane to the genome, focusing on changes that occur in the vicinity of the NE
through advanced imaging, genomic and transcriptomic approaches.
Aim 3: Investigate strategies to reduce DDR and delay cardiomyopathy in PKP2 deficient mice.
We hypothesize data that PKP2 mutation induces P53-dependent DNA damage response (DDR), which may
exacerbate ARVC disease progression. Genetic epistasis experiments and pharmacological approaches will
investigate how the P53-dependent DDR contributes to PKP2-dependent cardiomyopathy.
Defining pathological changes to nuclear architecture that precede overt myocardial structural remodeling
will reveal exciting opportunities for new therapeutic strategies aimed at slowing ARVC disease progression by
restoring nuclear envelope homeostasis or preventing the DNA damage response.

Public health relevance
PROJECT NARRATIVE Ventricular arrhythmias and sudden cardiac arrest, as well as cardiac dysfunction, are major causes of mortality and morbidity, carrying great economical and societal impact. Our research focuses on an inherited disease called “arrhythmogenic right ventricular cardiomyopathy” caused by mutations in the PKP2 gene, coding for a desmosome protein, plakophilin-2. We will use modern physiology, genomics, proteomics, and microscopy methods to investigate the mechanisms underlying the onset of the disease at the molecular level.